Enhancing Recovery Outcomes in Alcohol Use Disorder: Cognitive Training as an Adjunct to Treatment

Project Summary/Abstract
Programmatic investigation of neurocognitive functioning in alcohol use disorder (AUD) has revealed
widespread and sustained impairments. Despite conceptual relevance to treatment efficacy, few AUD
interventions have been directed to the remediation of these impairments. The proposed K01 is responsive to
this gap. It will answer critical questions regarding the potential of cognitive training (CT), applied as an adjunct
to inpatient treatment, to improve cognitive recovery and post-discharge functional outcomes in AUD.
The PI, Dr. Lewis, is an early career cognitive neuroscientist, committed to alcohol science and the
development of novel interventions for AUD. His basic science background was directed toward facilitating
abstinence in individuals with AUDs. His clinical research has focused on the investigation of alcohol-associated
neurocognitive perturbations. The proposed K01 will facilitate his integration of these aims into the development
of a research program directed toward novel interventions promoting neurocognitive and functional recovery.
The proposed research and training benefit from a diverse, multidisciplinary mentoring team, leveraging
expertise in cognitive neuroscience, addiction, cognitive training, computer science, and biostatistical analysis.
The training supported by this K01 award will include the development of expertise in advanced
methods/analysis of longitudinal health interventions, and the development of knowledge and skill bases in
human-computer interaction theory, facilitating Dr. Lewis’ ability to develop individualized, adaptive computer-
based interventions.
The current project will investigate the efficacy of two experimental cognitive training interventions in a sample
of inpatients in treatment for AUD. While the effectiveness of CT to enhance function is supported by diverse
literatures, it remains largely unexamined in AUD. The current proposal will question the degree to which
cognitive training interventions can “transfer” cognitive gains to untrained tasks/domains, and improve overall
executive functioning. It will apply conceptual models from the CT and alcohol literatures to identify factors
associated with CT efficacy. The impact of cognitive training on functional outcomes, including post-discharge
drinking, will be investigated. Finally, relationships between cognitive recovery during treatment and post-
discharge adaptation will be interrogated. Thus, the proposed work will be of substantial import to public health,
alcohol science, and will inform future intervention efforts.

Public health relevance
Project Narrative Alcoholism is characterized by widespread neurocognitive impairments, however despite substantial advances in the intervention and treatment of alcohol use disorders, exceptionally few studies have been directed to improving these deficits. The proposed work leverages computerized cognitive training, applied as an adjunct to inpatient treatment, to enhance neurocognitive recovery. The project informs public health and future intervention efforts by interrogating factors critical to intervention efficacy and clarifying relationships between neurocognitive recovery and treatment outcomes, including post-discharge alcohol consumption.